Support of Yerkes National Primate Research Center

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To provide collaborating researchers data networking of medical imaging, molecular databases, and telemedicine for brain, heart, eye and other human diseases.????